A comprehensive study of tandem repeat variation as a cause of Alzheimer's disease

Tandem Repeat Expansions (TREs), most commonly of triplet repeats such as poly(CAG), are known to
underlie >40 different human neurological diseases. While the majority of TREs identified to date have been
found in late-onset neuro-degenerative disorders such as hereditary ataxias and Huntington disease, TREs
have been identified in patients with AD and certain types of dementia. In addition to these expansions of short
tandem repeats (STRs, with motif sizes between 1 and 6 base pairs), copy number variation of larger repeats
with motifs ≥10bp, also known as Variable Number of Tandem Repeats (VNTRs), has recently been linked to
risk of AD. However, despite this evidence that variation in tandem repeat (TR) sequences can act as the
causative mutations in some cases of AD and dementia, there have been no concerted efforts in AD cohorts to
either systematically screen for novel TREs, or to genotype VNTR copy numbers.
Newly developed bioinformatic approaches that can be applied to analyze Whole Genome Sequencing
(WGS) data now provide an opportunity to fill this knowledge gap. Utilizing the expertise and knowledge that
we have gained working on other large datasets, we propose to apply these approaches to analyze ~62,000
genomes sequenced by the Alzheimer's Disease Sequencing Project that are available to the community, in
addition to a further ~48,000 control genomes from TOPMed, and will use these data to investigate two major
hypotheses:
1. We hypothesize that some cases of AD are caused by rare, highly penetrant pathogenic TREs. Using
novel bioinformatic tools that can identify TREs, we will search for rare TREs that are observed only in AD
samples, or which show significant enrichment in AD cases compared to controls, and thus are likely
causative for AD. Potentially pathogenic TREs will then be validated by PCR or long-read sequencing in
available DNA samples.
2. We hypothesize that common polymorphic copy number variation of TRs of all motif sizes can act as
genetic risk factors for AD. Short tandem repeats (STRs) with motif sizes 1-6bp will be genotyped with
hipSTR. VNTRs will be genotyped using read depth to estimate diploid copy number. We will analyze
available WGS data from ~20,000 sporadic late-onset AD samples and ~90,000 unrelated controls,
generating copy number estimates for >1 million STRs and ~150,000 VNTRs genome-wide, which will be
used to perform association analysis of TR copy number with AD status in a case:control study.
Given that TREs, and polymorphic variation in STRs and VNTRs, both represent established mutational
mechanisms that contribute to a variety of late-onset neuro-degenerative conditions, we believe that the study
of TRs in AD represents a logical step that has a high likelihood of uncovering novel genetic causes of AD.

Public health relevance
Although >40 tandem repeat expansions (TREs) have been identified in a variety of late-onset neurological diseases, including in patients diagnosed with Alzheimer’s disease (AD) and dementia, there have been no concerted efforts to systematically screen for novel TREs in AD cohorts. Similarly, recent studies have identified copy number variations in large tandem repeats as a risk factor for Alzheimer’s disease. Using novel bioinformatics approaches, in this proposal we will analyze exome sequencing data from ~62,000 AD samples and controls generated by the Alzheimer's Disease Sequencing Project, supplemented with ~48,000 TOPMed controls, to identify novel TREs and tandem repeat variants that are responsible for AD.